Monitoring Human Exposome with Extracellular Vesicle Tricorder

ABSTRACT
With escalating challenges of climate change and social inequality, there is an urgent need for tools that can
monitor the influences of the exposome on human health across large populations. Due to the heterogeneity and
complexity of biological responses in the body, the capacity to obtain organ-level insights from a simple blood
draw is much desired.
Extracellular vesicles (EVs) are bilayer membrane structures of diameters 30 – 1000 nm, and they are released
into the bloodstream by cells throughout the body, at concentrations on the order of 1010 per ml. Their molecular
content of proteins, dsDNA oligomers, microRNAs, mRNAs, and other analytes, may play multiple functional
roles via EV trafficking, and may also provide a diagnostic report back on the tissue of origin. As such, EVs
provide a unique opportunity to study the health impact of environmental exposures through blood analyses.
The long-term goal of this proposed program is to conduct population-level exposomic surveillance through the
development of a minimally invasive method that can provide a systems view of health status. The method will
be capable of monitoring tissue-specific signatures across individual organs and organ systems through
measurements of circulating EVs. The overall objective of this project is to develop, validate, and apply the
analytical infrastructures (technologies, software, and resources) that powers the method, focusing on
investigating the environmental impact on the human lungs as a proof-of-concept. To establish the technological
foundation of this project, we will integrate an exciting technology trio collectively termed the Extracellular Vesicle
Tricorder. The first technology, VET-seq (Vesicle Epitope Transcript Sequencing), is a droplet-based sequencing
method that resolves the organ source of circulating EVs by detecting EV proteins and RNA cargoes
simultaneously at single-vesicle resolution. The second technology, OrganView, aims to sort and assemble
scrappy information carried by EVs into meaningful biological messages with organ specificity. The third
technology, VPU (Vesicle Processing Unit), integrates a sensitive nanoparticle method, digital microfluidics, and
on-chip immunoassay, to facilitate population-level analysis of EVs.
Towards these challenging goals, I have assembled a multidisciplinary research team to bring together
complementary expertise in micro-nanotechnologies, molecular epidemiology, EV biology, bioinformatics and
statistical modeling, lung cancer, and infectious diseases.
The proposed research is highly innovative because it harnesses an emerging class of analytes (EV omics) to
develop an unconventional systems approach for monitoring the influence of environmental exposures on human
health. Overall, the new concepts, technologies, and resources derived from this work will augment current
methods for exposome research, with the potential to deepen our understanding of human exposome and reveal
unknown health threats in our environment.

Public health relevance
PROJECT NARRATIVE Extracellular vesicles (EVs) are shed into the bloodstream by all cells in the body, providing a unique opportunity to monitor the health impact of environmental exposures through liquid biopsies. Here we propose a technology framework integrating bulk and single EV omics, nanotechnologies, and microtechnologies to extract the blood fingerprints of organ-specific biological responses to life course experiences. The proposed methodologies, technologies, as well as data sets, will be of high value to both basic and translational research communities.